X-RAY CRYSTALLOGRAPHIC AND BIOCHEMICAL STUDIES OF TRANSCRIPTION FACTORS

The Ying-Yang I protein (YYI) is a novel zinc-finger DNA-binding protein capable of transcriptional activation or repression and sequence-specific initiator element binding in class 11 nuclear gene promoters. Studies are being undertaken to explore the interactions of YY I with other components of the RNA polymerase II machinery. MALDI-MS is assisting in determining and characterizing the potential targets of interaction.